Neuroimmune Treatment for AUD: Testing Moderators of Clinical Response and Mechanisms of Action

PROJECT SUMMARY/ ABSTRACT
Only a small proportion of individuals with past-year AUD received treatment. As such, development of
novel, efficacious pharmacotherapies for AUD is a high research priority that may lead to higher treatment
utilization and success rates. Establishing moderators of treatment response and mechanisms of action is an
imperative step towards identifying predictors of good clinical response and furthering precision medicine.
Modulation of immune function is one promising treatment target for addiction. Through activation of immune
cell receptors, sustained heavy alcohol use induces a proinflammatory state, which contributes of AUD
symptomatology. Negative affect is multi-faceted construct and common feature of AUD that is consistently
associated with poorer treatment outcomes and may be linked to inflammation induced by chronic alcohol use.
Anti-inflammatory therapies are shown to reduce levels of negative affect among individuals with psychiatric
disorders. As such, reductions in facets of negative affect may be a potential mechanism of action involved in
neuroimmune modulation in AUD. In regard to candidate moderators, research across disciplines shows that a
particularly pronounced inflammatory profile might be more amenable to neuroimmune treatment. Examination
of sex differences in response to immune treatment is also supported by several fields of research and
delineated by NIH as a priority consideration that can inform clinical interventions. This proposal is based on
recent indications that ibudilast, a neuroimmune modulator, is a potentially efficacious pharmacotherapy for
AUD. An initial screening of ibudilast in the Sponsor's laboratory showed that following stress exposure,
ibudilast promoted a stronger recovery of positive affect and strengthened the influence of negative affect on
craving. The objective of this NRSA application is to foster my development as a clinical scientist with a focus
on medications development for AUD, psychoneuroimmunology, and quantitative methods. This proposal will
draw from an ongoing and funded 12-week clinical trial of ibudilast recruiting a treatment-seeking sample of
AUD. Given the limited knowledge about how this class of therapy operates in human samples of AUD and
who is most treatment responsive, the proposed study will investigate potential moderators of clinical response
and mechanisms of action by leveraging data from this clinical trial of ibudilast. Specifically, Aim #1 tests the
hypothesis that facets of negative affect will significantly mediate the relationship between treatment and heavy
drinking. Aim #2 tests the hypothesis that peripheral proinflammatory biomarkers and sex will serve as
moderators of clinical response to ibudilast. These Aims will be tested using a sophisticated analytic approach
including longitudinal multilevel moderation and mediation models. The present study represents an important
step in further immune pharmacotherapies for AUD and, with the support of my mentoring team, my scientific
development as an independent clinical alcohol researcher with an interest in medications development.

Public health relevance
PROJECT NARRATIVE Alcohol use disorder (AUD), along with other psychiatric disorders, is associated with inflammation in the brain and body. Ibudilast, a neuroimmune modulator with anti-inflammatory properties, has been proposed as a novel pharmacotherapy for AUD. Given the limited knowledge about how this class of therapy operates in human samples of AUD, this proposal seeks to test potential moderators of clinical response, including peripheral proinflammatory biomarkers and sex as well as mechanisms of action, namely, facets of negative affect, by leveraging data collected from a randomized clinical trial of ibudilast enrolling treatment-seeking individuals with AUD.